RENIN INHIBITOR A64662--VASCULAR AND HORMONAL EFFECTS

The purpose of this protocol is to exploit the ability of a renin inhibitory peptide to reduce ALL formation, with a goal of assessing the contribution of ALL to the control of the renal circulation, adrenal aldosterone release, modulation of their responsiveness to ALL with shifts in sodium intake, and renal sodium handling.